Cryobioprinting for Shelf-Ready Tissue Fabrication and Storage

Abstract
Three-dimensional (3D) bioprinting has paved a new avenue for fabricating intricate cell-laden tissue
constructs. So far, bioprinting has been adopted in myriad applications such as tissue engineering, tissue
model engineering, and organoid production, among others. There are, however, challenges regarding the
fabrication and storage of shelf-ready 3D-bioprinted tissue constructs. Due to the intrinsic complexities involved
in most bioprinting processes, including the broadly adopted extrusion bioprinting, using this method as an on-
site fabrication technique can be cumbersome, or sometimes impractical under a number of scenarios.
Furthermore, the lack of a functional approach for long-term storage of cell-laden tissue constructs precludes
the shelf-availability of pre-made bioprinted products. Here, we propose to develop a unique cryobioprinting
strategy for simultaneously fabricating and storing cell-laden volumetric tissue constructs through seamlessly
combining cell-laden extrusion bioprinting and cryopreservation. The cryobioprinting performances will be
investigated by designing, fabricating, and storing cell-laden constructs made of cryoprotective bioinks using a
freezing plate with precisely controllable temperature. The in situ freezing process is further anticipated to
promote the printability of cell-laden hydrogel bioinks to achieve freeform structures otherwise oftentimes
inconvenient with direct extrusion bioprinting. We believe that our cryobioprinting will emerge as a single-step
method for concurrent tissue biofabrication and storage.

Public health relevance
Narrative The goal of this project is to develop a unique cryobioprinting strategy for simultaneously fabricating and storing cell-laden volumetric tissue constructs through seamlessly combining extrusion bioprinting and cryopreservation. It is believed that our cryobioprinting will emerge as a single-step method for concurrent tissue biofabrication and storage.